Experimental Irradiators

PROJECT SUMMARY/ABSTRACT
The Experimental Irradiators Shared Resource (EISR) maintains and operates sources of ionizing
radiation for use in experimental and preclinical studies by Sidney Kimmel Comprehensive Cancer Center
(SKCCC) Members. The resource supports discovery research in DNA damage, cancer biology, radiation
biology, immunology and preclinical and translational research using cell models; xenograft, orthotopic and
syngeneic tumor models; and advanced genetically modified mouse models of cancer. Services performed
by the resource staff include training in the operation of the instruments, advising users on the design of
experiments, treatment planning (dosimetry) and educating users on new technologies. Resource staff
oversee all instrument operations, assist users and operate the instruments when necessary, and conduct
appropriate instrument maintenance and repair. The resource is also available to nonmembers on an
increased-fee basis when not in use by Members. EISR resources include a parallel-opposed dual X-ray
source system, an X-ray source system, an image-guided orthovoltage small-animal radiation research
platform (SARRP) and two Cs-137 irradiators. The SARRP, located in the SKCCC Cancer Research
Building II, is equipped with onboard cone beam CT to guide precise focal irradiation of small animals,
mimicking human radiation treatments. SARRP represents highly sophisticated technology initially
developed at Johns Hopkins and is under continuous development to incorporate molecular optical
(bioluminescence and fluorescence) tomography for response assessment. These advances offer users
unparalleled opportunities for precision radiation treatments and testing in model systems relevant for clinical
translation.
SKCCC Managed Shared Resource
Reporting Period: January 1, 2020 to December 31, 2020